Injury Prevention in a Home Visitation Population

DESCRIPTION (provided by applicant): Injury remains the leading cause of morbidity and mortality for U.S. children after the first year of life and the home is the leading location of injury for younger U.S. children. Previous trials have failed to achieve comprehensive and durable installation of home safety products to reduce exposure to injury hazards in the indoor environments of young children. Children of mothers who are eligible and enrolled in home visitation programs and children of mothers with elevated depressive symptoms have been shown to be at risk of injury in the home. Inadequate maternal supervisory behavior has been shown to increase the risk of home injury. One specific aim of this proposal is to test the efficacy of the installation of multiple, passive measures (i.e. cabinet locks, stairgates, smoke detectors, etc.) to reduce exposure to injury hazards in the homes of young children of first-time mothers and subsequent medically-attended injury. The primary outcome will be a 50% reduction in medically-attended injury due to a reduction in injury hazard exposure in children who are randomized to the intervention compared with the control group over a 24-months follow-up. A second aim is to identify sub-groups of mothers and children who benefit most from the intervention by examining potential moderators of maternal depressive symptoms, the intensity of supervisory behavior, and child temperament and activity, on the intervention and subsequent injury outcomes. We will recruit 1000 children of first-time, low-income mothers who are participating in a home visitation program. These children, at 3 to 8 months of age, will be randomized to a home safety installation intervention (experimental group) or a Reach Out and Read program (control group). The leading mechanisms of residential injury resulting in an emergency visit for US children are: cutting/piercing, struck/strike, fall, poison, and burns. Exposure to hazards related to these injury mechanisms will be modified by the comprehensive installation of safety products. At baseline and annual follow-up we will use the HOME Injury Survey, a 55-item validated instrument to quantify unintentional injury hazards in the indoor environment of homes with young children, to quantify hazards and to direct the installation intervention. This proposal will test the efficacy of an intervention to reduce exposure to injury hazards in the home and subsequent preventable and medically attended injury in young children of first-time, impoverished mothers. Residential injury results in more than 1.7 million emergency visits in children younger than 5 years of age annually in the U.S. resulting in over $3 billion in medical care costs and $800 per emergency visit. Therefore, interventions that can effect sizable reductions in childhood injury in the home could result in substantial reductions in pain and suffering while saving potentially hundreds of millions of dollars in healthcare costs.

Public health relevance
PUBLIC HEALTH RELEVANCE: Narrative This proposal will test the efficacy of an intervention to reduce exposure to injury hazards in the home and subsequent preventable and medically attended injury in young children of first-time, impoverished mothers. As residential injury results in more than 1.7 million emergency visits in children less than 5 years of age each year in the U.S. resulting in more than $3 billion in medical costs including $800 per emergency visit, interventions that can effect sizable reductions could result in substantial reductions in pain and suffering while saving potentially hundreds of millions of dollars in healthcare costs. The proposal is focused on a compelling population of households of at-risk mothers and their children less than 4 years of age. Narrative This proposal will test the efficacy of an intervention to reduce exposure to injury hazards in the home and subsequent preventable and medically attended injury in young children of first-time, impoverished mothers. As residential injury results in more than 1.7 million emergency visits in children less than 5 years of age each year in the U.S. resulting in more than $3 billion in medical costs including $800 per emergency visit, interventions that can effect sizable reductions could result in substantial reductions in pain and suffering while saving potentially hundreds of millions of dollars in healthcare costs. The proposal is focused on a compelling population of households of at-risk mothers and their children less than 4 years of age. __SpecificAimsTextDelimiter__ A. Specific Aims and Hypotheses Injury is the leading cause of childhood morbidity and mortality in the United States. The home is the leading location of injury, accounting for over 13 million clinic visits and more than 4 million emergency visits each year in the United States.10 Healthcare expenditures for injury in US children amount to $3 billion annually in medical costs and over $800 per clinic or emergency visit.11, 12 Therefore, interventions that can significantly reduce medically-attended injury (emergency, office, or clinic visits) may prevent suffering and translate into substantial cost savings. Efforts to develop and test effective interventions to reduce injury in young children, and reach populations of greatest risk, have met with limited success. Indeed, multiple trials of parental education with or without the provision of safety devices have yielded inconsistent findings. Some investigators reported increases in parental knowledge and modest increases in the use of safety devices. However, subsequent reductions in childhood injury were either not measured or showed little impact. 13-15 A recent Cochrane Review summarized findings from these studies, noting that "there was a lack of evidence that interventions reduced rates...(over) a range of injuries."13 Clearly, there is a pressing need for an effective public health intervention to reduce childhood injury in the home that can be broadly implemented in a cost- effective manner. Injuries to young children in the indoor environment of the home are the result of a complex interplay of hazards in the built environment, child behavior and development, maternal psychology, and supervisory behavior. Studies of home safety have almost exclusively focused on education of parents. The provision of free or reduced cost equipment, based on the assumption that such an educational focus is most likely to increase safety and reduce injury risk, has been tested less often.16-18 One promising and rarely tested path to preventing injury in young children is to minimize exposure to injury hazards in the home through proper installation of safety devices. As part of a K23 Award, Dr. Phelan and the investigative team developed and pilot tested an intervention using an RCT design (N=355) in which homes were modified to reduce injury through the installation of multiple safety devices. Homes in the intervention group had a significantly lower number and density of hazards and intervention-group children had a 68% reduction in medically-attended injury rates compared with control children (from 7.7 per 100 child-years to 2.3 per 100 child-years respectively, p=0.026). The proposed study is a randomized, controlled trial to test the efficacy of this successful pilot intervention in a larger, high risk population, with more intense, and focused follow-up. Potential moderators of the intervention will be examined to identify sub-groups likely to benefit most. Specific Aim 1: To test the efficacy of the installation of multiple, passive measures to reduce exposure to injury hazards in the homes of young children of first-time mothers and reduce childhood injury. Hypotheses H1.1: The housing units randomly assigned to the intervention group will have a significant decrease in the number and density (number per area) of residential injury-related hazards compared with control group units. H1.2: Children who are randomized to the intervention group (e.g. installation of multiple, passive measures to reduce exposure to residential injury hazards) will have a 50% reduction in medically-attended injuries compared with children in the control group followed-up for 24-months in intention-to-treat analyses. Specific Aim 2: Identify sub-groups of mothers and children who benefit most from the intervention. Examine the potential moderating effect of maternal depressive symptoms, the intensity of supervisory behavior, and child temperament and activity, on the intervention and subsequent injury outcomes. Hypotheses H2.1: Persistent maternal depressive symptoms will moderate the effects of the intervention on childhood injury in the home; households and children of mothers with higher levels of symptoms will have more hazards and injuries. H2.2: Children of mothers with less intense maternal supervisory behavior over the course of the intervention follow-up will have higher rates of injury. H2.3: Children scoring high in activity on the Carey Temperament Scale will experience reduced benefits of the intervention on childhood injury in the home. Injury in the home environment is a pressing public health issue for US children and interventions which can successfully reduce home injury and identify populations most likely to benefit may prevent pain and suffering while potentially saving millions of dollars in healthcare costs.